Selective Probes for Alpha9* Nicotinic Acetylcholine Receptors

Project Summary:
Chronic inflammatory and neuropathic pain represents a substantial public health challenge, affecting an
estimated 20.9% of U.S. adults, with conventional treatments often limited by efficacy, tolerance, and addiction
risks. Recognizing the urgent need for innovative therapeutic strategies, this proposal focuses on the exploration
of nicotinic acetylcholine receptors containing the α9 subunit (α9*-nAChR) as novel targets for pain management.
Recent advances have highlighted the potential of α9*-nAChR selective modulation to offer significant relief in
neuropathic pain conditions through immune cell function regulation, presenting a promising avenue for drug
development. Our proposed research aims to address the critical gap in effective pain management by
developing and optimizing novel small-molecule probes targeting α9*-nAChRs. These probes are anticipated to
demonstrate superior anti-inflammatory and analgesic properties, devoid of the central nervous system side
effects associated with opioids. The project is structured around four specific aims, designed to advance our
understanding and therapeutic exploitation of α9*-nAChR systematically. Aim 1: We will develop a series of
small-molecule agonists and antagonists, utilizing structure-activity relationship (SAR) studies to enhance drug-
like attributes, including efficacy, potency, selectivity, solubility, and stability. Computational analyses will guide
the optimization process. Aim 2: Novel compounds will undergo rigorous testing to confirm their selectivity and
functional activity at α9*-nAChR, employing two-electrode voltage clamp recordings and a comprehensive
screening against other human and mouse nAChR subtypes to ensure specificity and minimize side-effect
liabilities. Leads that exhibit high potency and selectivity for α9*-nAChR vs. other human and mouse nAChR
subtypes will be tested for their inhibitory effect on ATP-mediated release of IL-1β by human mononuclear
phagocytes. After passing a Psychoactive Drug Screening Program (PDSP), compounds exhibiting potent anti-
inflammatory activities will be profiled pharmacologically (ADME/PK studies). Aim 3: Selected compounds will
be evaluated for their absorption, distribution, metabolism, excretion, and pharmacokinetic properties to identify
candidates with optimal drug-like characteristics for in vivo efficacy testing. Aim 4: The most promising α9*-
nAChR probes will be tested in mouse models of chronic inflammatory and chemotherapy-induced neuropathic
pain, aiming to establish their therapeutic potential, side-effect profile, and the sustainability of their analgesic
effects upon repeated administration. This interdisciplinary and collaborative project leverages cutting-edge
pharmacological, computational, and in vivo methodologies to unveil the therapeutic potential of α9*-nAChR
modulation in chronic inflammatory and neuropathic pain treatment. By elucidating the roles of α9*-nAChR in
pain pathways and developing novel agonists and antagonists, our research promises to pave the way for the
creation of non-addictive, effective pain relief options, thereby addressing a critical unmet medical need and
making a significant contribution to pain management and neuropharmacology.

Public health relevance
Narrative: Addressing the pressing public health challenge of chronic and neuropathic pain affecting nearly 21% of U.S. adults, our research targets the novel nicotinic acetylcholine receptors with the α9 subunit (α9*-nAChR) to revolutionize pain management. Through pioneering small-molecule probes for α9*-nAChRs, we aim to unlock significant anti-inflammatory and analgesic benefits, steering clear of the adverse effects tied to traditional opioids. This ambitious project not only seeks to fill a crucial gap in effective pain treatment but also to herald a new era in drug development against chronic inflammatory and neuropathic pain, promising a future where pain relief is both effective and safe.